INTRA ESOPHAGEAL BOTULINUM TOXIN INJECTION--ESOPHAGEAL ACHALASIA AND SPASM

This study is designed to compare the short-term and long-term efficacy of botulinum toxic injections to standard pneumatic dilation therapy for patients with symptomatic esophageal achalasia.